Regional Medical Library for Region 3 of the Network of the National Library of Medicine: Program

The Gibson D. Lewis Health Science Library of the University of North Texas Health Science
Center (HSC) proposes to host the Regional Medical Library (RML) for Region 3 of the Network
of the National Library of Medicine (NNLM) in order to support its mission of working through
libraries and other members to support a highly trained workforce for biomedical and health
information resources and data, improve health literacy, and increase health equity through
information. Region 3 will serve as a regional hub to develop a highly skilled workforce, ensure
proper stewardship of funds, and develop unique engagement opportunities for member
libraries and other organizations to carry out regional and national programs.
The Specific Aims of the RML Program Core, with numbering continued from the Overall Specific
Aims, will be to (6) blanket the region with programming and funding to achieve the NNLM
mission, with a focus on underserved communities, by leveraging and growing the library network;
(7) develop a highly-trained data science workforce and increase access to biomedical resources
and data through strategic partnerships, targeting programming, and through LIS engagement;
and (8) address consumer health issues while strategically targeting specific communities and
community organizations in partnerships with new and existing network members, along with
joint collaborations with other RMLs.
By offering different types of continuing education credit, Region 3 will be able to ensure that its
training offerings can attract and reach a wider set of professionals that serve underrepresented
and marginalized communities. Programming in of itself will be diverse and targeted, utilizing a
variety of modalities in order to sustain interest and create engagement in the region. Funding
will follow a similar vein and include award mechanisms that allow for discrete, targeted
outreach. A significant portion of all of this programming and funding will focus on developing
data science skills and competencies in the current and future workforce. For scalability, Region
3 will focus on partnering or jointly offering activities with network members and/or other
RMLs.